PILOT PROJECTS

The Pilot Projects Core (PPC) of the Lung Cancer Disparities Center (LCDC) in conjunction with our training and development program will support innovative research while simultaneously maximize training opportunities - two linked functions likely to push the area of lung cancer disparities research forward in important new directions.